An ethno-epidemiological study of the implementation and effectiveness of an innovative and comprehensive response to the evolving overdoseepidemic

PROJECT SUMMARY/ABSTRACT
Overdoses deaths have increased sharply in Canada and the US since the outset of the COVID-19 pandemic.
While fentanyl is a critical driver of North America’s overdose epidemic, rising fentanyl-stimulant polysubstance
use and ongoing drug supply changes (fluctuating fentanyl potency, adulteration of fentanyl with novel
psychoactive substances) are worsening the situation and pose challenges to overdose prevention and addiction
treatment approaches. There has been a lack of research into these emerging dynamics and how they intersect
with social, structural, and environmental influences to shape overdose vulnerability and the effectiveness of the
overdose response. Based in Vancouver, Canada, this study will employ an innovative ethno-epidemiological
approach to address this critical research gap by: (1) characterizing how evolving drug use patterns and supply
changes impact overdose vulnerability; (2) examining how changing drug use patterns and drug supply changes
intersect with social, structural, and environmental influences to impact the effectiveness of overdose prevention
interventions; and (3) exploring social, structural, and environmental influences on treatment outcomes for
existing and emerging opioid agonist treatment (OAT) approaches among fentanyl-stimulant polysubstance-
using and NPS exposed PWUD. Vancouver is the ideal setting to undertake the proposed research. Vancouver
had implemented innovative overdose prevention and addiction treatment interventions that led to significant
decreases in overdose deaths and that were later implemented – or are now being considered – elsewhere in
the US and internationally, including drug checking programs, supervised consumption sites, and low-threshold
oral and injectable OAT. This comprehensive overdose response is being adapted in response to rising overdose
deaths attributed to fentanyl-stimulant polysubstance use and drug supply changes, including by expanding
drug-checking approaches (benzodiazepine testing strips), expanding OAT options (e.g., oral and injectable
OAT), implementing supervised inhalation services, and integrating OAT a contingency management and
detoxification services. This study will be nested within the research infrastructure of the BC Centre on Substance
Use, which includes three NIDA-funded, longitudinal cohort studies of PWUD and a NIDA-funded drug-checking
program evaluation. This approach will enable epidemiologically-informed sampling and targeted recruitment of
PWUD and facilitate the integration of qualitative data and cohort-based and drug surveillance data. Extending
our ethno-epidemiological research to examine how a comprehensive response to the overdose epidemic is
being adapted to rising fentanyl-stimulant polysubstance use and drug supply changes will result in a more
nuanced and complete understanding of influences on the effectiveness of the overdose response than is
possible through epidemiological research alone. The proposed research is aligned with NIH and NIDA strategic
priorities and will generate evidence critical to optimizing the response to the overdose epidemic.

Public health relevance
PROJECT NARRATIVE This study will employ an ethno-epidemiological approach to examine how drug supply changes and rising fentanyl-stimulant polysubstance use impact overdose vulnerability and the effectiveness of a comprehensive response to the overdose epidemic in Vancouver, Canada, including robust harm reduction and addiction treatment interventions. This study operates in connection with three NIDA-funded cohort studies and a NIDA- funded drug-checking evaluation project, and involves the integration of ethnographic and qualitative data with clinical, behavioral, and drug surveillance data. This study addresses critical research gaps by examining emerging dynamics fueling the overdose epidemic, and will generate evidence critical to optimize public health responses.